Development of Contrast Enhanced Functional Ultrasound Imaging to Monitor Induced Neuroplasticity in Chronic Spinal Cord Injury

Project Summary/Abstract
Functional ultrasound (fUS) imaging is a relatively new alternative to standard functional neuroimaging
approaches (e.g., fMRI, PET) that utilizes ultrafast plane wave pulsing schemes to achieve improved signal-to-
noise ratio and spatiotemporal resolution (1 msec, 100 µm). However, current fUS approaches isolate blood flow
signal from tissue motion solely on the basis of relative velocity. This results in the exclusion of slow
microcirculatory flows, a critical limitation given the recent implication of capillaries in the direct regulation of
cerebral and spinal cord blood flow. The primary goal of this project is to develop a microcirculation-sensitive
fUS modality by utilizing nonlinear excitation of circulating microbubble contrast agents. Cervical spinal cord
injury (SCI) will be utilized as a model for the development of this new method and subsequent assessment of
its utility. Specifically, intermittent hypoxia (IH), a promising method for the induction of neuroplasticity and
restoration of healthy breathing function in chronic SCI, will be used to induce localized activation and long term
facilitation in the phrenic motor neuron pool. First, contrast-enhanced functional ultrasound (CE-fUS) imaging
conducted in the intact spinal cord will be utilized to optimize transmit parameters (i.e., pulse repetition frequency,
nonlinear pulsing schemes) and post-processing methods (i.e., motion correction, generalized linear modeling).
Spatiotemporal filtering techniques will be utilized to isolate tissue perfusion and larger microvascular flow signals
for independent analysis, heretofore impossible with existing fUS imaging techniques. CE-fUS imaging will then
be applied to characterize the initial degeneration of neurovascular coupling in the perilesional region following
controlled contusion SCI, and subsequent fundamental microvascular changes induced by repeated IH exposure
during the chronic phase of injury. Successful completion of these studies will elucidate the fundamental
microvascular changes that mediate IH-induced neuroplasticity following SCI. Moreover, CE-fUS imaging will
enable further studies of differential hemodynamic response patterns at different levels of the vasculature, and
will serve as a fundamental tool for the assessment of neurovascular pathologies and developmental therapies
in future work.

Public health relevance
Project Narrative The proposed fellowship centers on the development of a novel contrast-enhanced functional ultrasound imaging method capable of detecting neurovascular coupling at the microcirculatory level. This new modality will be applied in the context of intermittent hypoxia-induced neuroplasticity in the phrenic motor neuron pool, a promising avenue for the improvement of breathing function in patients living with chronic cervical spinal cord injury. Successful completion of the proposed work will result in both an understanding of the fundamental microvascular changes that mediate neuroplasticity in response to intermittent hypoxia, and a new, versatile imaging tool with exceptional sensitivity and spatiotemporal resolution for the investigation of neurovascular pathologies.